Mechanisms of Microbial Competition During Salmonella Infection

PROJECT SUMMARY
The microbiota is a critical frontline barrier that protects the host from invading microorganisms and keeps
resident opportunists in check. Frank pathogens such as Salmonella enterica serovar Typhimurium (STm),
however, are adept at overcoming microbiota-mediated colonization resistance to cause dysbiosis and disease.
Under homeostasis, antimicrobial short-chain fatty acids (SCFAs) produced by the microbiota protect the host
by restricting pathogen replication through cytosol acidification. During infection, STm uses its type III secretion
systems (T3SS) to trigger an inflammatory response that depletes SCFA-producing commensals. Current
paradigm holds that the depletion of SCFA-producing species is a pre-requisite for luminal STm expansion.
However, using an antibiotic-naïve mouse model we have observed that STm blooms 1000-fold 3-4 days prior
to the onset of overt inflammation when SCFAs are abundant and the community composition of the microbiota
is undisturbed. This implies that STm employs an as-of-yet undescribed strategy to restore pH homeostasis and
grow in the presence of SCFAs during gastrointestinal colonization. Our preliminary findings suggest that proton-
consuming metabolic pathways, including the amino acid decarboxylases CadA and SpeF, alleviate SCFA
growth inhibition in vitro and are required for full virulence in vivo, yet it is unclear whether these pathways
specifically mediate growth in the presence of SCFAs within the host, or how STm secures the metabolites that
fuel these pathways in the nutrient-restricted gastrointestinal environment. I hypothesize that during colonization
of the gastrointestinal tract, STm uses its T3SS to obtain host-derived amino acids that fuel proton-consuming
reactions and restore pH homeostasis in the presence of commensal-produced SCFAs.
The objective of this application is to elucidate how STm adapts to the intestinal environment and to use
this understanding to develop my own independent research program that investigates how enteric pathogens
overcome intrinsic protective barriers so that we may uncover new therapeutic approaches for bolstering
colonization resistance in high-risk patients. In AIM1 we will assess the contribution of proton-consuming
metabolic pathways in restoring pH homeostasis and growth in the presence of SCFAs in vitro, and investigate
the role these pathways play in mediating early ecosystem invasion in vivo using conventional and gnotobiotic
animal models. In AIM2 we will use bacterial genetics, murine infection models, and metabolomics to determine
how STm uses its virulence factors to engineer a new gastrointestinal niche that supports dysbiotic
Enterobacteriaceae expansion under homeostatic conditions. This mechanistic approach to microbiota research
will provide causal links between pathogen-mediated environmental remodeling and changes in microbial growth
conditions that cannot be gleaned from solely cataloging bacterial species. Successful completion of this work
will reveal opportunities to enhance innate host defenses by identifying and targeting the metabolic pathways
enteric pathogens use to overcome colonization resistance.

Public health relevance
PROJECT NARRATIVE The microbiota protects the host from microorganisms that cause disease in unprotected or immunocompromised individuals. Enteric pathogens such as Salmonella enterica, however, are adept at circumventing and weakening these protections and in doing so render the host susceptible to infection. Here, we propose to elucidate the mechanisms by which Salmonella overcomes microbiota-mediated colonization resistance with the goal of uncovering new therapeutic strategies to restore this important protective barrier.